Dynamic Analysis of Tumor and Microenvironment in Patients Undergoing Immunotherapy

PROJECT SUMMARY / ABSTRACT
Harnessing the immune system to fight cancer has proven to be remarkably effective, but most patients who
are treated with immunotherapy do not respond. Our understanding of what determines the response to
immunotherapy remains poor. Immune recognition and destruction of cancer cells occurs at the level of the
tumor microenvironment (TME), but the human TME has been difficult to study due to a lack of suitable
preclinical models, the challenges in acquiring adequate patient tumor tissues, and a lack of analytic tools to
study the complex interplay between cancer and the immune system. In this proposal, we will directly
investigate the changes immunotherapy produces in the TME of patients over time by utilizing samples from a
serial multi-site tumor biopsy approach in two trials of in situ vaccination (ISV) in follicular lymphoma. we are
leveraging technological advances in single cell genomics and multiparameter histology platforms to study
limited samples in great depth as well as bioinformatics advances that allow us to extract important information
from large complex datasets with a goal of identifying the key tumor-immune interactions before treatment and
the evolution of immune responses with treatment. We will focus on how T-cell phenotypes and clonotypes
change after ISV and relate to tumor responses (Aim 1), on whether tumor cell responses to ISV may enhance
the generation of anti-tumor immunity (Aim 2), and on interactions between cells in the TME (Aim 3). This
comprehensive approach will yield critical insights into the determinants of successful immunotherapy.
This work will be undertaken by Tanaya Shree, MD PhD, a fellow in the Department of Oncology at the
Stanford University School of Medicine. Dr. Shree completed a dual MD/PhD program at Cornell/ Rockefeller
University/ Sloan-Kettering where she discovered that tumor-associated macrophages helped murine breast
cancer survive chemotherapy and that dampening critical macrophage functions could improve chemotherapy
efficacy. At Stanford, Dr. Shree continues to investigate cancer and the immune system, having developed two
investigator-initiated immunotherapy trials, studied the immune health of lymphoma survivors, and established
expertise in immunology and high-dimensional assays for studying mechanisms of immunotherapy.
Dr. Shree will be mentored in this work by Ronald Levy, MD, and Hanlee Ji, MD. Both are physician-scientists
who have made significant contributions to the fields of cancer immunotherapy and genomics and have
mentored numerous successful independent researchers. In addition, a distinguished committee of advisors,
consisting of Drs. Crystal Mackall, Garry Nolan, and Ash Alizadeh, will guide her research and career
development. Dr. Shree’s training plan focuses on didactic and practical training in advanced immunology,
bioinformatics, and biostatistics to complement her substantial skills and experience in biomedical research.

Public health relevance
PROJECT NARRATIVE Immunotherapy has become a powerful tool against cancer, but most patients who are treated with immunotherapy, by checkpoint blockade, cellular therapies, vaccination or other strategies, do not respond. The proposed research seeks to better understand what happens in tumors when we treat patients with immunotherapy. By studying tumors directly from patients at multiple timepoints during treatment with immunotherapy, and by using modern comprehensive techniques to do so, this proposal will add significantly to our current knowledge and highlight avenues for new improved immunotherapy strategies that work in more patients and in more types of cancer.